Defining mechanisms of microbe-microbe interactions in chronic wound infection

Project Summary
Staphylococcus aureus is a leading cause of human infection worldwide. Investigations into Staphylococcus
aureus pathogenesis have focused on mono-species infections and the impact of co-infecting microbes on S.
aureus physiology during infection remains understudied but critically important. My recent work has focused on
characterizing S. aureus physiology during mono- and co-infection with Pseudomonas aeruginosa using next-
generation sequencing techniques. The current application builds logically on this work and is focused on
characterizing the interactions between S. aureus and co-infecting microbes within chronic wound infections.
The overall goal of this application is two-fold: 1) to define the metabolic interactions that occur between S.
aureus and co-infecting microbes during infection (Specific Aim 1); and 2) to expand on these findings to
determine the impact of microbe-microbe interactions on S. aureus physiology within human infections (Specific
Aim 2). This work is likely to yield important discoveries that will aid in our understanding of the underlying
mechanisms of microbe-microbe interactions within chronic polymicrobial infections.

Public health relevance
Project Narrative Chronic human infections are frequently polymicrobial, with interactions between microbes leading to increased disease severity. The primary objective of this application is to define how interactions between Staphylococcus aureus, a key pathogen in multispecies infections, and co-infecting microbes alter S. aureus physiology and enhance human wound infections. The ultimate goal is to design new therapeutic strategies that can interfere with these microbe-microbe interactions and improve disease outcomes.